A Longitudinal MRI Study of Brain Development in Fragile X Syndrome

DESCRIPTION (provided by applicant): This application A Longitudinal MRI Study of Brain Development in Fragile X Syndrome, is a proposal to conduct a longitudinal MRI study of very early brain and behavior development at 6, 12 and 24 months in infants with Fragile X Syndrome (FXS). This study will examine how the trajectory and growth of brain development in infants with FXS compares to early brain development in infants (at high-risk for autism) who later develop an autism spectrum disorder and in infants with typical brain development. Since many children with FXS also have an autism spectrum disorder (ASD), the design of this study will allow us to contrast brain development profiles in ASD children without FXS, as well as those FXS children who may also have an ASD. The high-risk autism subjects and typical controls are being collected as part of a funded Autism Centers of Excellence (ACE) Network entitled, A Longitudinal MRI Study of Infants at Risk for Autism, currently in year 2. Three of the ACE Network sites will be participating in this project (two clinical data collection sites: UNC and Washington University, and a data coordinating site at Montreal Neurological Institute). Resources in this network, and available to this proposal, include expertise in imaging methods for infant brain and behavioral tools for detecting early (emerging) signs of autism. The final sample of FXS in this study will include 37 infants with FXS (with either 2 or 3 longitudinal scans each). For data analysis in this current proposal, the infants with FXS will be compared to the ACE dataset of 68 infants with ASD (without FXS), 163 infants at risk for ASD but considered ASD(-), and 66 TYP controls. Analysis will examine longitudinal MRI and behavioral data at 6, 12 and 24 months for these children. Preliminary data from our group suggests that the brain volume profiles of FXS and autistic children are significantly different at age 2. Individuals with FXS show a pattern of brain abnormalities at age 2 that differs from typical and developmentally-delayed (non-FXS) two year olds (with marked temporal lobe white matter enlargement, and ~40% caudate enlargement), and autistic two year olds with FXS differ strikingly from autistic non-FXS two year olds. By contrasting the early brain development of infants with FXS, we will be able to address several important hypotheses about the trajectory of early post- natal brain overgrowth (regions, tissues, structures and fiber tracts) in FXS, as measured on MRI and DTI, and its potential relationship to clinical features, particularly those features characteristic of and associated with ASD. This study has the potential to distinguish specific behavioral, genetic, and neurobiological features that characterize infants with FXS in comparison to infants at risk for autism without FXS and those with typical development. This proposal is a response to RFA PA-07-284 that requests submissions examining the interface of autism and Fragile X Syndrome.

Public health relevance
PUBLIC HEALTH RELEVANCE: "A Longitudinal MRI Study of Brain Development in Fragile X Syndrome," is a proposal to study very early brain and behavior development at 6, 12 and 24 months in infants with Fragile X Syndrome (FXS) using Magnetic Resonance Imaging (MRI) and Diffusion Tensor Imaging (DTI). We will examine how the trajectory and growth of brain development in infants with FXS compares to early brain development in infants at high-risk for autism (who later develop an autism spectrum disorder), as well as typical developing infants. We will address several important hypotheses about the trajectory of early post-natal brain overgrowth (regions, tissues, structures and fiber tracts) in FXS, as measured on MRI and DTI, and its potential relationship to clinical features, particularly those features characteristic of ASD. This study has the potential to distinguish specific behavioral, genetic, and neurobiological features that characterize infants with FXS in comparison with infants at high-risk for autism and those with typical development. "A Longitudinal MRI Study of Brain Development in Fragile X Syndrome," is a proposal to study very early brain and behavior development at 6, 12 and 24 months in infants with Fragile X Syndrome (FXS) using Magnetic Resonance Imaging (MRI) and Diffusion Tensor Imaging (DTI). We will examine how the trajectory and growth of brain development in infants with FXS compares to early brain development in infants at high-risk for autism (who later develop an autism spectrum disorder), as well as typical developing infants. We will address several important hypotheses about the trajectory of early post-natal brain overgrowth (regions, tissues, structures and fiber tracts) in FXS, as measured on MRI and DTI, and its potential relationship to clinical features, particularly those features characteristic of ASD. This study has the potential to distinguish specific behavioral, genetic, and neurobiological features that characterize infants with FXS in comparison with infants at high-risk for autism and those with typical development. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS (SA) This application "A Longitudinal MRI Study of Brain Development in Fragile X Syndrome," is to conduct a longitudinal MRI study of very early brain and behavior development at 6, 12 and 24 m (months) in children with Fragile X syndrome, resulting in a final sample of 25 FXS subjects. This study will take advantage of an existing recently NIH-funded Autism Centers of Excellence (ACE) Network entitled, "A Longitudinal MRI Study of Infants at Risk for Autism" (start date: July 2007). This ACE Network includes four clinical data collection sites (UNC, UW, CHOP, WashU) and a Data Coordinating Center (DCC) (MNI). This proposal will involve a subset of two of these clinical data collection sites (UNC and WashU), and the DCC at MNI. The ACE Network study will collect neuroimaging and behavioral data on 544 infants who are at risk for an autism spectrum disorder (ASD) by virtue of having an older sibling with autism (referred to as 'high risk sibs'), and will enroll: (1) 400 six m old infants, who are at risk for autism by virtue of having an older sibling with autism, and conduct follow-up assessments at 12 and 24 m (on the portion of the 6 m olds who develop symptoms of ASD by 12 m of age and the portion of 24 m olds who meet criteria for ASD at 24 m); (2) 144 12 m high-risk infant sibs will be enrolled and followed up at 24 m; and (3) a comparison group of 66 typically-developing (TYPs) controls at 6, 12 and 24 m. These two subject groups (high-risk sibs and TYPs) will serve as comparison data for the FXS infants collected in this proposal. Note: for data analysis in this current proposal, the combined sample size will include: 36 infants with FXS (29 full mutation, 7 premutation), 68 high-risk infants with ASD, 163 high-risk sibs who are considered ASD(-), and 66 TYP controls with longitudinal MRI and behavioral data at 6, 12 and 24 m. The proposed study will investigate how early brain development in FXS differs from brain development in typically developing and autistic-non FXS children. Since many children with FXS also have an ASD, the design of this study will allow us to contrast brain development profiles in autistic children with and without FXS, as well as those FXS children without ASD. Preliminary data from the UNC group suggests that the brain volume profiles of these groups are significantly different. The ACE Network brings together investigators with expertise in the early detection of autism and those who specialize in pediatric brain imaging analysis methods. This proposal builds on the considerable infrastructure and resources already established for the ACE Network, exciting new findings in early brain and behavioral development in autism, and on new data on brain structure in FXS at age 2 years. Funding for this proposal is time-sensitive. To take full advantage of the infrastructure in place for the funded ACE Network, this study should ideally occur as close as possible to the time frame for the ACE Network (start date July 2007, first subjects enrolled January 2008). This proposal is in response to PA-07-284, which requests applications focused on the shared neurobiology of Fragile X syndrome and Autism. The specific aims of this project are directly relevant to the desired emphasis of this program announcement, as they are focused on characterizing early neurodevelopment in FXS (e.g., brain structure and pathways) and contrasting this with the same period in autism. By longitudinally studying children with FXS, we will be able to distinguish specific behavioral, genetic, and neurobiological features that characterize infants with FXS (with and without symptoms of ASD) in comparison with infants at risk for autism without FXS and those with typical development. Note: A glossary of terms used in this grant are listed in Appendix I. Specific Aims (SA) are as follows: " SA 1: To characterize the longitudinal brain development in infants (6 to 24 m) with FXS (with full mutation) in comparison to typically developing controls (TYP)*: o 1a. Examine total brain growth (from 6 to 24 m) and selected brain volumes (from 12 to 24 m). We hypothesize that the FXS children, relative to TYP controls, will show a marked increase in rate of brain growth in selected substructures (e.g., caudate) across the 6 to 24 m interval. o 1b. Examine white matter (WM) development using diffusion tensor imaging (DTI) at 6,12, and 24 m. We hypothesize that FXS children will show deficits in neural circuitry development (e.g., frontal-striatal pathways) as indicated by smaller fractional anisotrophy (FA) and mean diffusivity (MD) in selected fiber tracts. " SA 2: To contrast the developmental brain profiles in infants with FXS (with full mutation) and in infants with autism (without FXS) by: o 2a. Comparing group differences in total brain size, selected brain volumes, and DTI measures between FXS and high risk infant sibs with ASD at 6, 12, and 24 m. o 2b. Quantifying the effects of group (FXS vs. high risk infant sibs with ASD) on brain development trajectory, and specifically comparing brain development (i.e., brain growth) in infants with FXS to high risk infant sibs. o 2c. Explore the association between brain development abnormalities and severity of ASD features (e.g., social deficits, repetitive behaviors) in FXS and high risk infant sibs (both those ASD+ and ASD-), and comparing the differences in brain-behavior association between these groups. The full range of autism severity will be examined in the two distinctive populations. " SA 3: To examine the relationship between gene (FMR1) function (e.g., measures of FMRP), and abnormalities of brain morphology and behavior over time. A primary hypothesis is that FMRP levels will be associated with caudate volume and increased rate of caudate growth in early childhood (i.e., between time points), and that these differences in gene function also will be related to particular cognitive and behavioral characteristics (e.g., stereotyped-repetitive behavior). * Note: The specific aims for the ACE Network are provided below to place the SAs of the present proposal in context. An overview of the ACE IBIS Network and Supplement are provided in Appendix IV. Specific Aims of the ACE IBIS Network and the Supplement: 1. To characterize the longitudinal trajectory (at 6, 12 and 24 m) of brain volumes and WM development in high-risk sibs who exhibit the full syndrome of ASD by 24 m, (b) high risk-sibs who exhibit ASD symptoms by 24 m, but not the full ASD syndrome, (c) non-symptomatic high-risk sibs, and (d) low-risk, typically- developing infants (without a 1o or 2o relative with an ASD). 2. To characterize the longitudinal development of selected brain volumes in ASD individuals from 12 to 24 m. 3. To characterize the longitudinal development of white matter (WM) using diffusion tensor imaging (DTI) in autistic individuals from 6 to 24 m. 4. To examine the developmental pattern of brain-behavior relationships between 6 and 24 m. 5. To characterize the association between the age at which ASD symptoms (e.g., social, communication, repetitive behaviors) appear, and the pattern of developmental brain differences in high risk sibs. 6. To characterize the extent to which developmental brain abnormalities in high risk sibs are associated with the severity of ASD and associated symptoms (e.g., social and selected cognitive characteristics). 7. To compile a unique database of behavioral and MRI/DTI data, and DNA, in 60 children with ASD and 66 TYP controls, across the 6 to 24 m age interval, for later sharing with other researchers.